Dopaminergic Therapy for Inflammation-Related Anhedonia in Depression

PROJECT SUMMARY
Depression is a heterogenous and widespread disorder (lifetime prevalence >20%) and confers a substantial
societal burden. Current pharmacological therapies are effective for many patients; however, more than 30%
fail to achieve remission, and even responders exhibit significant residual symptoms including anhedonia.
One pathophysiologic pathway shown to contribute to symptoms of depression is inflammation. Elevated
inflammatory markers are observed in both the periphery and central nervous system in a significant proportion
of patients with depression, particularly in patients that are resistant to conventional antidepressant therapies.
Basic and clinical findings indicate that inflammation can affect striatal dopamine availability and release to
contribute to symptoms of anhedonia and reduced motivation. We previously reported a relationship between
inflammation and functional connectivity (FC) in dopaminergic reward circuitry in patients with major
depressive disorder (MDD) whereby patients with higher plasma C-reactive protein (CRP) concentrations
exhibited lower FC between the ventral striatum (VS) and ventromedial prefrontal cortex (vmPFC), which was
correlated with symptoms of anhedonia. Preliminary data from our current study demonstrate that VS-vmPFC
FC connectivity was increased after acute administration of the dopamine precursor, levodopa (L-DOPA),
compared to placebo in patients with high CRP (indexed as CRP >2 mg/L). Clinical and translational evidence
from our group and others suggests that inflammation may impact corticostriatal circuits by decreasing the
availability and release of dopamine, indicating that increasing dopamine with L-DOPA can reverse the impact
of inflammation on this circuit.
in MDD patients with high infla
We hypothesize that treatment with L-DOPA will improve depressive symptoms
mmation and anhedonia by increasing FC in reward circuitry and improving
motivation. To determine a dosing strategy for L-DOPA that affects VS-vmPFC FC and behavior in the R61
Phase, medically-stable and medication-free adults with MDD, plasma CRP >2 mg/L, and high anhedonia will
receive treatment with three doses of L-DOPA compared to placebo (randomized, double-blind, crossover).
Patients will undergo resting-state and task-based functional magnetic resonance imaging (fMRI) to probe FC
in reward circuity in relation to bioavailability of L-DOPA at baseline and after 1 week at each dose. Safety and
tolerability and data on the effect of L-DOPA on anhedonia and motivation in relation to target engagement in
the brain (FC) will also be assessed. If L-DOPA increases VS-vmPFC FC at our Go/No-Go threshold, we will
compare the dose of L-DOPA exhibiting optimal target engagement and tolerability to placebo in the R33.
Subjects meeting the above criteria will be randomized to L-DOPA or placebo to determine whether L-DOPA
has potential for clinical impact (Go/No-Go criteria: change in depression severity) and whether response is
influenced by change in FC, anhedonia and/or motivation. Additional baseline behavioral, biological and MRI
measures will be collected for use as possible predictors of response and to enhance interpretation of results.

Public health relevance
PROJECT NARRATIVE A significant portion of adult patients with depression exhibit increased inflammation, which has been associated with impaired corticostriatal reward circuitry and symptoms of anhedonia. Preclinical and clinical evidence from our group and others demonstrates that inflammation impacts corticostriatal circuitry by decreasing the availability and release of dopamine. The current proposal builds upon our prior work and aims to develop potential new treatment interventions for adult patients with depression and high inflammation by targeting reward circuitry and anhedonia through the use of a dopaminergic therapy.